PLACEBO CONTROL TRIAL OF THALIDOMIDE IN PATIENTS WITH TUBERCULOSIS AND/OR HIV+

This study will evaluate the mechanism of action of thalidomide to selectively inhibit release of tumor necrosis factor (TNF) in patients with tuberculosis and/or HIV infection. It will assess the safety and efficacy of thalidomide, as judged by symptoms, physical examination, and studies of microbiological, immunologic, hematological, renal and hepatic status.